FDA Vet-LIRN Capacity-Building of Ohio ADDL to support bacterial identification of foodborne pathogens

This proposal from the Ohio Department of Agriculture (ODA) is in response to Funding
Opportunity Announcement (FOA) PAR-18-604 from the Food and Drug Administration
(FDA) Center for Veterinary Medicine (CVM) Veterinary Laboratory Investigation and
Response Network (Vet-LIRN).
This proposal from ODA’s Animal Disease Diagnostic Laboratory (ADDL) addresses the
following key project areas:
1. Purchase of equipment needed to improve diagnostic capacity for Vet-LIRN
case investigations of foodborne pathogens.
a. We are requesting funds to support to the purchase of a Bruker MALDI
Biotyper® Sirius RUO System for bacterial identification.
2. Conduct increased testing in response to a new need identified by the
VPO.
a. MALDI-TOF technology allows for high throughput identification
of bacterial isolates to reduce turnaround time of bacterial
culture and isolation.
Additionally, participation in additional projects such as method development and/or
method validation/improvement and matrix extension work as determined by the VPO
may be included in the capacity-building funds. This proposal will maintain the capacity
of our laboratory to conduct molecular diagnostic testing for high-throughput sample
processing capability and data analysis by maintaining active service contracts to
reduce any delays in testing due to equipment malfunctions or needed repairs.

Public health relevance
FDA CVM Vet-LIRN PROGRAM (U18) GRANT PROPOSAL FOR FOA # PAR-18-604 from the OHIO DEPARTMENT OF AGRICULTURE, ANIMAL DISEASE DIAGNOSTIC LABORATORY PROJECT NARRATIVE The FDA Veterinary Laboratory Investigation and Response Network (Vet-LIRN) enables analyses of animal diagnostic samples and animal food/drug products. Through Vet-LIRN, the FDA leverages the expertise of a national network of veterinary diagnostic laboratories to provide additional capability and capacity to strengthen the overall national food safety system. This Vet-LIRN capacity building project strengthens the capacity, collaboration, and integration of food-safety laboratories and networks, thereby facilitating an effective and coordinated response to future human and animal food safety issues. The Ohio Animal Disease Diagnostic Laboratory (ADDL) will offer its expertise and services to support testing and surveillance projects under direction from Vet-LIRN, provide surge capacities for testing using standardized Vet-LIRN methods, and assist Vet-LIRN with emergency response testing. This proposal will support the costs associated with the purchase of a Bruker MALDI Biotyper® Sirius RUO System for bacterial identification utilized in Vet-LIRN case investigations and antimicrobial resistance monitoring.